Immune dynamics shaping blood brain barrier integrity in virally suppressed people with HIV

PROJECT SUMMARY/ABSTRACT
Neuropsychiatric complications persist in people with HIV (PWH) despite suppressive antiretroviral therapy. Two
common, often disabling conditions in PWH are cognitive impairment (CI) and major depressive disorder (MDD).
However, the pathophysiology of central nervous system (CNS) dysfunction in PWH that results in these
conditions remain elusive and thus a HIV high priority topic. The trafficking of activated peripheral blood
mononuclear cells (PBMCs), specifically CD14+CD16+ monocytes, into brains of virally suppressed (VS)-PWH
has emerged a putative contributor to neuroinflammation. We propose to test our hypothesis that VS-PWH will
have blood brain barrier (BBB) disruption mechanistically linked to targeted, circulating soluble
cytokines/chemokines and upregulation of PBMC surface proteins. The latter interact with tight junction and
adherens junction proteins to weaken the BBB, promoting PBMC diapedesis into brain. BBB disruption may
promote persistent neuroinflammation and altered neuronal activity contributing to neuropsychiatric sequela. To
this end, we propose cross-sectional imaging and lumbar puncture to assess BBB integrity, with baseline and
longitudinal neuropsychiatric assessments and blood sampling. 350 VS-PWH and 100 HIV-uninfected (HIV-)
individuals will be recruited from the Johns G. Bartlett Clinic within the Johns Hopkins Hospital and in the
surrounding Baltimore community. First, we aim to assess the effects of well-controlled HIV on the BBB and its
contribution to neuropsychiatric conditions (Aim 1). We will assess BBB integrity using a novel, non-contrast
magnetic resonance imaging technique that uses water-extraction-with-phase-contrast-arterial-spin-tagging
(WEPCAST), to determine BBB permeability to water, and thereby to small molecules. We have shown this to
be sensitive to BBB change in mild cognitive impairment, a precursor to Alzheimer’s disease. Moreover, we have
found WEPCAST to be well-tolerated and estimate PS values well in VS-PWH. Second, we aim to assess the
relationship between circulating soluble markers, PBMC-associated markers, and BBB permeability to small
molecules, which collectively may promote diapedesis into brain (Aim 2). We target factors implicated in a
heightened transmigration of activated PBMCs across the BBB into brain, where they may contribute to neuronal
damage and neuropsychiatric burden in VS-PWH. Finally, we aim to examine the relationship of activated
PBMCs that transmigrate an intact BBB model to BBB permeability to small molecules (Aim 3). We innovate with
the real-time assessment of ex vivo cellular function (BBB model) and in vivo BBB measures (WEPCAST). After
5 years of funding, this R01 will advance our understanding of BBB integrity and related PBMC migration into
the brains of VS-PWH, which may contribute to neuroinflammation and related neuropsychiatric burden. These
findings will inform next steps in the development of therapeutic approaches to minimize PBMC contribution to
neuroinflammation in VS-PWH.

Public health relevance
PUBLIC HEALTH NARRATIVE The cognitive and mental health burden among virally suppressed people with HIV (VS-PWH) remains a major issue in HIV care. Integrity of the blood brain barrier (BBB) and immune cells migrating into the brain may contribute to neuroinflammation and related neuropsychiatric burden in VS-PWH. To better understand how HIV affects the BBB and the role of neuroinflammation, we will perform brain scans using a novel, noninvasive technique to measure BBB breakdown and tests of cognitive and mental health in a group of VS-PWH and demographically similar HIV-uninfected individuals.